Administrative Core

Migraine, one of the most common primary headache disorders, affects 1 in 4 US households. This complex
neurologic disorder is mediated in part by alterations in trigeminal somatosensation, which manifests as head/fa-
cial pain and/or trigeminal allodynia. Effective treatments for migraine are still limited, and our knowledge about
human trigeminal system at baseline and migraine conditions are sparse. In response to RFA-NS-22-018, HEAL
Initiative: Discovery and Functional Evaluation of Human Pain-associated Genes & Cells, we propose to
form the Penn Human Precision Pain Center (Penn HPPC) to elucidate molecular, cellular, epigenetic, and
physiological profiles of human trigeminal ganglion (TG) sensory neurons at baseline and migraine conditions.
The Penn HPPC will be composed of Penn and international investigators with multidisciplinary expertise. The
PI, two MPIs, and two co-Is are currently collaborating on a single-soma deep RNA-seq of human dorsal root
ganglion (DRG) project, which form a strong foundation for this application. The Penn HPPC will contain three
cores and perform three projects. Among them, the administrative core will serve as the sole organizational
and administrative entity for the Penn HPPC, which will support and unite research activities of different cores
and research projects by providing leadership, resources, and oversight. The administrative core will also com-
municate with other U19 centers and the NIH HEAL Initiative PRECISION Human Pain network entities to ensure
and promote the overall synergy and success. The administrative core will be led by the PI, Dr. Luo, and three
MPIs, Drs. Li, Olausson, and Wu, and supported by financial and administrative coordinators. Specifically, the
administrative core will foster communication and sharing of resources, data, and ideas among the Penn HPPC
investigators, support and enhance training and mentoring of junior colleagues, ensure sound financial and reg-
ulatory oversight, coordinate external oversight and ensure timely progression toward milestones, and dissemi-
nate findings to the NIH HEAL Initiative PRECISION Human Pain network entities and scientific community in a
timely manner. In short, the Penn HPPC administrative Core will provide all necessary administrative support
to ensure that the scientific goals and milestones of the Penn HPPC are met.